TASK A11: MODELS FOR CYTOMEGALOVIRUS AND HERPES SIMPLEX VIRUSES

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.